A population-based approach to single CTC analysis in metastatic breast cancer outcome

PROJECT SUMMARY AND ABSTRACT
In the United States, metastatic breast cancer (MBC) accounts for over 40,000 deaths each year. Estrogen
receptor-positive (ER+) MBC is present in up to 80% of MBC patients, and is treated by hormone therapy-
based regimens. Given the high global prevalence of ER+ breast cancer, hormone therapy has a greater
global impact than any other therapy in cancer medicine. However, >50% of ER+ MBC patients will exhibit de
novo or acquired resistance to hormone therapy and once this occurs, patient prognosis is much more dismal.
Currently, ER+ MBC treatment decisions are mainly based on pathological examinations of tumor tissues or
biopsies. However, tissues or biopsies are not always obtainable and can yield inaccurate findings due to
intratumoral heterogeneity. Moreover, MBC progression is a highly dynamic process in which the metastatic
tumors constantly and rapidly change their genomic fingerprints to evade the attacks from systemic therapies
and immune system, leading to drug resistance. To promptly and accurately detect these changes and adjust
treatment plans, repeated tumor biopsies would be needed, which is extremely infeasible in real clinical
settings. Therefore, it is important to develop novel non-invasive approaches for the prospective prediction and
real-time monitoring of treatment responses, which can lead to more precise and timely treatment decisions. In
MBC patients, circulating tumor cells (CTCs) are shed into blood by tumors, have extremely high malignant
potential, and are arguably the most important subset of tumor cells to monitor and treat. Unlike tissues or
biopsies, CTCs can be non-invasively enumerated and characterized in real-time as “liquid biopsy”. The
landmark study by our Co-Investigator, Dr. Massimo Cristofanilli (NEJM. 2004, 351(8)) showed that CTC
number independently predicts MBC survival. That finding led to the clearance of CellSearchTM as the only
CTC enumeration system approved by the Food and Drug Administration. However, although instrumental in
predicting survival, a recent randomized trial (JCO. 2014, 32(31)) showed that treatment changes based on
CTC enumeration alone did not prolong patient survival, highlighting the necessity of further in-depth genomic
characterizations of single CTCs. Single-CTC analyses are highly challenging both technically and analytically,
and would have been impossible in large-scale population studies without the recent emergence of the single-
cell next-generation sequencing (NGS) technology. We recently established a pipeline on the enrichment,
enumeration, isolation, amplification, and NGS analysis of single CTCs. Based on this pipeline, we propose a
study to comprehensively characterize CTC genomes of ER+ MBC patients using a population-based
approach. As, to our knowledge, the first population study of single-CTC NGS analysis in MBC patients, the
findings of this study will significantly improve the potential of CTCs in the clinical management of MBC, by
precisely tailoring treatment to the genomic make-up of individual CTCs from individual patients.

Public health relevance
PROJECT NARRATIVE We will use a population-based approach to conduct whole exome sequencing and targeted gene panel sequencing of single and pooled circulating tumor cells (CTCs), in order to identify CTC mutations/genes that are predictive of the survival and treatment response in patients with estrogen receptor-positive metastatic breast cancer (MBC). As, to our knowledge, the first population study of single-CTC next-generation sequencing in MBC patients, the findings of this study will significantly improve the potential of CTCs in the clinical management of MBC, by precisely tailoring treatment to the genomic make-up of individual CTCs from individual patients.